Effects of bimagrumab on body composition, insulin sensitivity, and bone in adults with obesity

PROJECT SUMMARY/ABSTRACT
In adults with obesity, 5-10% weight loss improves cardiometabolic risk, including insulin
sensitivity, but not all components of weight loss are equally beneficial. Individuals would preferentially
lose fat mass, particularly visceral fat, a major cardiometabolic risk factor. However, 20-40% of weight lost
through diet, pharmacotherapy, or surgery in adults with obesity is lean mass, which mitigates improvements in
insulin sensitivity—consistent with the fact that skeletal muscle is responsible for most insulin-mediated glucose
disposal—and contributes to weight regain by reducing resting energy expenditure. Loss of bone mass is another
unintentional consequence of weight loss, which increases the risk of osteoporosis and fractures. Therefore,
optimum weight loss strategies should preserve muscle and bone mass. If a lifestyle intervention (diet and
exercise) does not achieve weight loss goals, options include pharmacotherapy such as the glucagon-like
peptide 1 receptor agonist (GLP-1 RA), semaglutide. Although semaglutide has the detrimental effect of reducing
lean mass with weight loss, it does suppress bone resorption and increase bone formation in adults with obesity
and stable weight. This suggests bone loss may not be a side effect of semaglutide, in contrast to other
therapies for obesity, but this has not been investigated.
Bimagrumab, an investigational new drug for obesity that inhibits the activin type II receptor
(ActRII), may be anabolic to muscle and bone. Blockade of the myostatin/activin-ActRII pathway increases
muscle mass, reduces fat mass, and improves insulin sensitivity while increasing bone formation, reducing bone
resorption, and increasing bone mass in rodents. Early clinical data in adults with obesity and type 2 diabetes
suggest that bimagrumab reduces visceral fat mass and increases lean mass. Although just one dose of
bimagrumab increases whole body insulin sensitivity, it is unclear whether bimagrumab improves skeletal muscle
insulin sensitivity. One dose of another ActRII inhibitor increases bone formation and decreases bone resorption,
but longer-term effects on bone are unknown.
We hypothesize that in a double-blind, placebo-controlled trial of 65 adults with obesity
randomized in 2:2:1 ratio to bimagrumab (30mg/kg IV at 0, 4, 16, 28, and 40 weeks), semaglutide 2.4mg
SQ qweek, or placebo, bimagrumab will result in metabolic improvements in muscle (Aim 1), visceral fat
(Aim 2), and bone (Aim 3) vs. semaglutide or placebo over 52 weeks as an adjunct to a lifestyle
intervention for weight loss. To investigate whether bimagrumab improves tissue-specific insulin sensitivity,
20 subjects will undergo hyperinsulinemic–euglycemic clamps with [18F]FDG-PET/MRI at baseline and Week 52.
Understanding the effects of bimagrumab vs. semaglutide or placebo (as an adjunct to a lifestyle
intervention for weight loss) on muscle, visceral fat, and bone will determine whether inhibiting the
myostatin/activin-ActRII pathway reduces metabolic risk more than other treatments for obesity.

Public health relevance
PROJECT NARRATIVE In adults with obesity seeking treatment, weight loss should be composed almost exclusively of fat mass, but loss of lean mass and bone are unintentional consequences of weight loss, which has detrimental effects on health by mitigating improvements in insulin sensitivity, contributing to weight regain by reducing energy expenditure, and increasing the risk of frailty, falls, and fractures. Preclinical and early clinical data suggest that bimagrumab, an investigational new drug for obesity that inhibits the activin type II receptor (ActRII) inhibitor, may be anabolic to muscle and bone. We hypothesize that in a double-blind, placebo-controlled trial of 65 adults with obesity randomized to bimagrumab, semaglutide (which is FDA-approved for weight loss), or placebo, bimagrumab will result in metabolic improvements in muscle, visceral fat, and bone vs. semaglutide or placebo as an adjunct to a lifestyle intervention for weight loss over 52 weeks.